IGF::CL::IGF THE SRP SUPPORT FOR THE BREAST/PROSTATE/LUNG AND THE MULTI-SCALE/ESOPHAGEAL/COLORECTAL CISNET MEETINGS AS PART OF THE CISNET CONSORTIUM. MEETINGS

THE SRP REQUIRES SUPPORT FOR THE BREAST/PROSTATE/LUNG AND THE MULTI-SCALE/ESOPHAGEAL/COLORECTAL CISNET MEETINGS AS PART OF THE CISNET CONSORTIUM. MEETINGS TO BE HELD MAY 6-13, 2015